Role of transcription factor activating protein-2 beta (AP-2β) in corneal epithelial cell fate determination and stratification

Corneal surface pathologies such as corneal conjunctivalization arise mainly from the loss of limbal epithelial
stem cells (LESCs) and can lead to corneal neovascularization, opacity and ultimately, blindness. Although the
role of neural crest cells (NCC)-derived periocular mesenchyme (POM) has been established in development of
the corneal stroma, its role in development of the corneal limbus and corneal epithelium has yet to be determined.
It has been shown that transcription factors including activating protein-2 beta (AP-2β) play key roles in the
development and differentiation of the POM. However, the role of AP-2β in POM-mediated corneal epithelial
development remains largely unknown, as AP-2β null mice die soon after birth. To address this, we have
specifically deleted AP-2β in the NCC of mice, using the Wnt1Cre-recombinase system (AP-2β NCC KO). Two
major defects observed in these mice were corneal thinning and vascularization and contributing to this
phenotype were an absence of the corneal endothelium and impairment in corneal epithelial stratification. Our
scRNA-seq analyses along with RNAscope and immunohistochemistry revealed an absence of keratin-12 (K12),
a corneal epithelial marker, and expansion of keratin-15 (K15) and K13, conjunctival epithelial specific markers,
into the corneal epithelium of the mutant when compared to controls. Further investigations revealed an absence
of ABCB5, a LESC marker, from the limbal region of the mutants indicating a conjunctival-like phenotype due to
the absence of AP-2β in the NCC. In addition, bone morphogenetic protein (BMP) 4, a key player in corneal
mesenchymal-to-epithelial signaling known to be modulated by Wnt/β-catenin during corneal epithelial
stratification, was absent in the epithelium of the mutants further suggesting a crucial role of AP-2β in regulating
corneal epithelial cell fate and stratification. Thus, our overarching hypothesis is that expression of AP-2β
in the POM is critical for corneal epithelial cell fate determination and stratification through modulation
of the Wnt/β-catenin signaling pathway. In the current proposal we aim to determine: 1) the developmental
timing and fate of LESC in the AP-2β NCC KO mutants and 2) whether Wnt/β-catenin/BMP4 –signaling axis-is
disrupted in the mutant and contributes to the ocular surface defects. Overall, these studies will contribute to our
understanding of the gene regulatory network (GRN) controlling corneal epithelial cell fate determination and
stratification, and the pathogenesis of diseases marked by corneal thinning, neovascularization and
opacification.

Public health relevance
The mature corneal epithelium is continuous with the conjunctival epithelium, separated by a distinct peripheral limbus. Absence of the limbal region leads to an invasion of conjunctival cells into the cornea (conjunctivalization) resulting in corneal opacity associated with corneal thinning, neovascularization, inflammation and eventually vision loss. A number of genetic disorders such as Peters’ Anomaly and acquired conditions such as inflammation, infection and injury that include chemical or thermal burns and burn from radiation are known to result in conjunctivalization. Recently, by deleting a transcription factor, AP-2β, in specific cell types during early ocular development in mice, we observed a similar pathological condition as seen in human corneal conjunctivalization including corneal thinning, neovascularization and opacity. In the current proposal, we aim to understand the contribution of AP-2β in the POM, and its derivatives, in regulating corneal epithelial cell fate and stratification. We will also test a topical treatment strategy to mitigate this pathological condition.